Rhythms in Cholinergic Interneuron Activity Mediate Drug-Taking Behaviors

Project Summary/Abstract
Substance use disorders (SUDs) pose a significant global public health concern, yet effective treatment options
remain limited. One often overlooked aspect is the role of circadian rhythms in SUDs. Clinical studies have shown
rhythmic patterns in drug-taking and drug-craving behaviors. People with SUDs also often experience disrupted
rhythms, including sleep disturbances. Moreover, irregularities in circadian rhythms can contribute to the
susceptibility of developing SUDs. Despite this, the mechanisms underlying the connection between circadian
rhythms and SUDs are not yet fully understood. Circadian rhythms have been found are present in the
mesolimbic dopamine system, which plays a critical role in behaviors associated with SUDs, such as drug-taking.
For instance, diurnal rhythms have been observed in dopamine release and extracellular tone in the nucleus
accumbens (NAc), a vital brain region in the mesolimbic system. Our lab has also found that disturbing the
molecular clock affects the firing patterns of medium spiny neurons, which encompass both DR1 and non-DR1
cells in the NAc. Interestingly, the NAc is also made up of cholinergic interneurons (CINs), potent regulators of
dopamine dynamics and motivated behaviors. For example, CIN firing patterns mediate dopamine release via
the release of acetylcholine acting on nicotinic receptors on dopamine terminals. Additionally, activation of CINs
enhances extinction behaviors in a rodent model of addiction-like behaviors. However, research on CIN activity
rhythms and their potential connection to motivated behaviors like drug-taking remains limited. This proposal
seeks to bridge the existing gap by investigating the correlation between circadian rhythms and the intrinsic
properties and activity of CINs in the NAc, aiming to elucidate their potential relevance to addiction-like behaviors.
My prior research suggests that there are diurnal rhythms in CIN modulation of dopamine release and that CIN
activity may be higher midway through the light cycle in the NAc. Based on these data, I will directly determine
the rhythms in intrinsic properties and activity of CINs in the NAc with electrophysiology. Additionally, I will explore
how chronic drug exposure, specifically cocaine self-administration, influences diurnal variations in CINs. My
hypothesis is that there are specific times within the light cycle when CIN activity is elevated, aligning with drug-
taking behaviors, and that chronic drug exposure alters these rhythms. Furthermore, I will investigate the effects
of disrupting the molecular clock in CINs within the NAc and determine its impact on drug-taking behaviors. I
hypothesize that disrupting the molecular clock in CINs will alter the diurnal rhythms in addiction-like behaviors.
These novel studies will contribute to a better understanding of the relationship between rhythms and the
underlying mechanisms, particularly the involvement of CINs, in SUDs. By gaining insights into the rhythmic
nature of these mechanisms, we may uncover new avenues for the development of personalized treatments for
individuals with SUDs.

Public health relevance
Project Narrative Substance use disorders (SUDs) are debilitating and lack effective treatments. This proposal aims to explore the involvement of circadian rhythms in cholinergic interneurons and their potential link to addiction-like behaviors. By gaining a better understanding of the relationship between circadian rhythms and neural mechanisms underlying SUDs, we may improve current treatments or develop novel ones.